ER stress sensor PERK functions in localization of neuronal growth factors through CaMKII

Abstract
Neuronal function depends on the precise localization and release of neuromodulators, such as growth
factors, in response to stimuli. Our lab recently identified an unexpected, but exciting role for ER stress sensor
PERK, PKR-like ER kinase, in neuronal growth factor localization. Specifically, in the absence of PERK, a
dendritic TGF-ß-like growth factor is mistargeted to the axons, while an axonal insulin-like-growth factor (IGF) is
retained in the cell body. Interestingly, PERK is genetically linked to the tauopathies Alzheimer’s Disease (AD)
and Progressive Supranuclear Palsy (PSP). At least two of the three genetic variants have decreased kinase
activity, but it is unknown how decreased activity is a risk for disease. Impairment of PERK’s role in the correct
localization of neuroprotective IGF and TGF-ß-like growth factors could provide a molecular connection to
neurodegeneration.
Because it is unclear how PERK may directly mediate growth factor localization, I asked whether PERK
functions through one of its known downstream targets. Strikingly, I found that CaMKII, a kinase whose function
is critical for neural plasticity and memory, is genetically downstream of PERK. Importantly, CaMKII has a known
function in axonal targeting of neuropeptides, which has the potential to explain PERK’s novel role in growth
factor localization. This proposal aims to define how PERK and CaMKII interact to control axonal-dendritic
targeting of select neuroprotective growth factors. To do this, I will test whether PERK acts through its kinase
activity, whether phosphorylation-dependent activation state of CaMKII affects growth factor localization, and
whether PERK directly phosphorylates CaMKII. The proposed studies will be completed primarily at Drexel
University under the guidance of the sponsor and co-sponsor; however, I will seek guidance from my
collaborators at UPenn, especially for the advanced in vitro kinase assays to test whether PERK directly
phosphorylates CaMKII proposed in Aim 2. Together with my sponsors, I have developed a comprehensive
training plan that addresses training in hypothesis-driven research, scientific communication and writing, and
career development, as well as augmenting my formal training in neuroscience. The overarching goal of this pre-
doctoral fellowship project is to guide me in preparing for an independent career in biomedical research, focusing
on the areas related to protein-based pathology in neurodegeneration.

Public health relevance
Project Narrative Precise axonal-dendritic targeting of neuronal growth factors is critical for neuronal function, but how they are targeted is largely unknown. We have found that an ER stress sensor protein, PERK, and a kinase associated with neural plasticity and memory, CaMKII, cooperate to control localization of two neuroprotective growth factors. This project will test the relationship between PERK and CaMKII in this novel pathway, which will not only advance our understanding of protein localization in neurons, but also may explain how PERK is genetically linked to neurodegeneration.